SCIENTIFIC AND TECHNICAL CONSULTING SERVICES ON CONTRACEPTIVE RESEARCH

Turhow consulting provides CRB with expertise in preclinical and early phase 1 clinical product development space on developing products that are multipurpose prevention technologies (e.g., a contraceptive with an anti-infective property, such as - HIV, bacterial vaginosis, etc.). Not surprisingly, this is beneficial to more than one ongoing grant/contract.